Renal Morbidity Following Kidney Cancer Surgery

DESCRIPTION (provided by applicant): The impact of significant loss of renal mass resultant from kidney cancer surgery is not fully known. Large clinical studies demonstrate that loss of kidney function correlates with an increased incidence of hospitalizations, cardiovascular events, and all-cause mortality. Patients with renal cell carcinoma (RCC) tend to be older, often have co-morbid conditions associated with lower baseline kidney function, and may be particularly sensitive to further loss of kidney function following kidney cancer surgery. Hence, there is a great need to determine the comparative effectiveness of alternative surgical approaches for RCC on kidney function and downstream clinical outcomes. The goal of this award period is for Dr. Leppert to achieve complete independence as an investigator in urologic health services research and expertise in RCC clinical outcomes. He will receive extensive training through the Clinical Research Track in the Graduate Program in Epidemiology at Stanford University, and through the specific aims of the project. The broad objective of this study is to determine the effect of kidney cancer surgery on kidney function and outcomes associated with chronic kidney disease (CKD) such as end-stage renal disease (ESRD), cardiovascular events, hospitalizations, and mortality. The specific aims of the project are to 1) establish an electronic data registry of persons that underwent kidney cancer surgery within the Veterans Affairs (VA) health care system, 2) characterize the change of kidney function due to specific types of kidney cancer surgery, and 3) to correlate the type of kidney cancer surgery received and post-operative kidney function with the risk of ESRD, conditions associated with CKD, cardiovascular events, hospitalizations, and all-cause mortality among RCC patients in the VA health care system. Ultimately, comparing these surgical strategies can provide opportunities to improve care for patients diagnosed with RCC.

Public health relevance
PUBLIC HEALTH RELEVANCE: The impact of kidney cancer surgery on chronic kidney disease and its associated clinical outcomes is not fully known. Comparing the effect of kidney cancer surgery on kidney function will help inform treatment decisions and provide opportunities to improve care and clinical outcomes for patients diagnosed with kidney cancer. The impact of kidney cancer surgery on chronic kidney disease and its associated clinical outcomes is not fully known. Comparing the effect of kidney cancer surgery on kidney function will help inform treatment decisions and provide opportunities to improve care and clinical outcomes for patients diagnosed with kidney cancer. __SpecificAimsTextDelimiter__ RESEARCH PLAN 10. Specific Aims Major Hypothesis: Loss of kidney function following kidney cancer surgery is associated with mortality, cardiovascular events, including non-fatal myocardial infarction, stroke, complications of peripheral arterial disease and heart failure, and progression to end-stage renal disease (ESRD) among users of the Veterans Affairs (VA) Health Care System. The gold standard treatment for the management of localized renal cell carcinoma (RCC) is surgical extirpation. Radical nephrectomy, which includes removal of the entire kidney, is the historic gold standard treatment for long-term cancer control.12, 13 Partial nephrectomy, which removes the tumor along with a margin of normal renal cortex, has been shown to offer equivalent oncologic outcomes for small renal tumors (<7cm).1 Nephron sparing surgical approaches, including partial nephrectomy, may be underused due to the increased risks and complexity of the surgery.14 Large clinical studies demonstrate that loss of kidney function correlates with an increased incidence of hospitalizations, cardiovascular events, and all-cause mortality.15 While the incidence of ESRD following donor nephrectomy is reported to be low,16 the impact of significant loss of renal mass resultant from kidney cancer surgery is not fully known. Patients with RCC tend to be older, and often have comorbid conditions associated with lower baseline kidney function (e.g., hypertension), are often found to have occult chronic kidney disease (CKD)17 and may be particularly sensitive to further loss of kidney function following kidney cancer surgery. Hence, we need to determine the degree to which partial nephrectomy and nephron sparing approaches influence long-term outcomes, both in terms of cancer outcomes as well as non-cancer outcomes that might be expected to differ based on differential degrees of impaired kidney function. Ultimately, comparing these surgical strategies can provide opportunities to improve care for patients diagnosed with RCC. Aim 1: To establish an electronic data registry of persons that underwent kidney cancer surgery within the VA health care system. Hypothesis 1A: Persons receiving kidney cancer surgery within the VA health care system represent a cohort at risk of renal morbidity, as they are disproportionately older, and have a high prevalence of medical co- morbidities and baseline chronic kidney disease. Hypothesis 1B: The utilization of partial nephrectomy and other nephron sparing approaches is rising, although radical nephrectomy remains the most common kidney cancer surgery performed in the VA health care system, even among patients with small renal masses (<7cm). Aim 2: To characterize the change of kidney function due to specific types of kidney cancer surgery among users of the VA health care system. Hypothesis 2A: Kidney cancer surgery significantly reduces kidney function. Hypothesis 2B: Partial nephrectomy and other nephron sparing approaches preserve significantly more kidney function than radical nephrectomy. Aim 3: To correlate the type of kidney cancer surgery received and post-operative kidney function with the risk of ESRD, conditions associated with CKD, cardiovascular events, hospitalizations, and all- cause mortality among RCC patients in the VA health care system. Hypothesis 3A: Patients receiving radical nephrectomy, when compared with nephron sparing surgery, will have higher incidence of mortality, cardiovascular events, including non-fatal myocardial infarction, stroke, complications of peripheral arterial disease and heart failure, and progression to ESRD among users of the VA Health Care System. Hypothesis 3B: An independent and graded association exists between the extent of post-operative chronic kidney disease and the risk of mortality, cardiovascular events, including non-fatal myocardial infarction, stroke, complications of peripheral arterial disease and heart failure, and progression to ESRD among users of the VA Health Care System.